Roles of Lig3 and XRCC1 Genes in Genome Stability

ABSTRACT
While the ATP production by oxidative phosphorylation in mitochondria provides the energy for the synthesis of
proteins, nucleic acids and other macromolecules, this process generates as a by-product reactive oxygen
species that present a unique challenge for the circular mitochondrial genome. Notably, the accumulation of
oxidative DNA damage in mitochondrial DNA inhibits the transcription of key electron transport proteins encoded
by the mitochondrial genome disrupting electron transport leading to a further increase in reactive oxygen
species. In addition to the reactive oxygen species generated within mitochondria, some environmental DNA
damaging agents preferentially cause damage in the mitochondrial genome compared with the nuclear genome.
Interestingly, although the oxidized base 8-oxoguanine is repaired, oxidative DNA damage also induces
degradation of the mitochondrial genome. Since there are multiple copies of the mitochondrial genome per
organelle, it has been suggested that the removal of damaged genomes by degradation serves to prevent
mutations. For oxidative DNA damage, it is not known what lesion(s) triggers genome degradation and whether
this reduces mutations. In Specific Aim 1, we will test the hypothesis that the MUTYH DNA glycosylase protects
the mitochondrial genome from mutation by stably binding to genomes with the 8-oxoG:adenine mispairs or the
8-oxoG:abasic site repair intermediate and targeting them for degradation using unique tools and reagents
developed by the PI and co-I. The proposed studies will elucidate the mechanisms that engage with oxidative
DNA damage in mitochondria to either repair the damage or target the damaged genome for degradation.
Specific Aim 2 builds upon a novel interaction identified between the mitochondrial DNA ligase, DNA ligase
IIIa (LigIIIa) , and NDUFAB1, an accessory subunit of complex I of the electron transport chain that provides
possible explanation as to why the LigIIIa inhibitor rapidly induces production of mitochondrial superoxide. We
will characterize the interaction between mitochondrial LigIIIa and complex I to determine whether LigIIIa has a
non-canonical role in complex I function, thereby linking mitochondrial DNA metabolism with oxidative
phosphorylation. Cancer and non-malignant cells respond very differently to the dysfunction caused by inhibition
of mitochondrial LigIIIa with cancer cells activating an inflammatory cell death pathway whereas non-malignant
cells activate mitophagy and pro-inflammatory cell stress pathways. In Specific Aim 3, we will delineate the
mechanisms and regulation of the cellular pathways that respond to mitochondrial dysfunction induced by
inhibition of mitochondrial LigIIIa in cancer and non-malignant cells. Alterations in mitochondrial function that are
usually associated with increased oxidative stress have been identified as the causative factor in certain human
metabolic and neurodegenerative diseases and implicated in inflammation, cancer and ageing. Thus, our
proposed studies will provide fundamental insights as to how mitochondria maintain their genome and suggest
how mitochondrial dysfunction can be mitigated or exploited to improve human health.

Public health relevance
NARRATIVE DNA damage by endogenous and environmental agents to nuclear and mitochondrial DNA has been identified as a causative factor in cancer, neurodegeneration and inflammation. In this project, we will determine how mitochondria deal with DNA damage, provide new insights into the relationship between mitochondrial DNA and energy metabolism and elucidate differences in how cancer and non-malignant cells respond to mitochondrial dysfunction. The results of these studies will advance our understanding of the causes of mitochondrial dysfunction and guide the development of novel therapeutic strategies for human diseases associated with mitochondrial dysfunction.